Influence of genetic variants on the pharmacokinetics and pharmacodynamics of combined oral contraceptive pill users

PROJECT SUMMARY (ABSTRACT)
Combined oral contraceptive pills (COCPs), containing both an estrogen and a progestin, remain the most
commonly used hormonal contraceptive method in the US, and overall, one of the most commonly prescribed
medications among all women. Despite its high prevalence of use, little is known about the pharmacogenomics
of COCPs, which are the relationships between genetic variations and interindividual variability in drug efficacy,
metabolism, and safety. Pharmacogenomic investigations have led to the development of actionable clinical
guidelines for over 40 drug-gene pairs, the majority of which involve drugs far less frequently prescribed than
COCPs. Given the utility of COCPs and similar steroid hormone-containing medications throughout a woman's
lifespan, it is imperative that we gain a better understanding of how individual genetic variation affects the wide
interindividual response to these drugs. However, a major hurdle faced in conducting pharmacogenomic
research with these medications is the lack of useful phenotypic data in existing biobanks. National genetic
consortia are primarily made up of men or postmenopausal women, thus necessitating the creation of new
biobanks that focus on reproductive-age women and collect data on phenotypes specific to steroid hormone
medications. We aim to build a novel biobank of 700 COCP users to both validate previously identified genetic
relationships among contraceptive implant users and to identify novel areas of the human genome associated
with steroid hormone metabolism, contraceptive mechanisms, and side effects. We will collect pharmacokinetic
outcomes from COCP users to evaluate the influence of CYP3A7*1C carrier status, which has been
associated with increased metabolism of other exogenous and endogenous steroid hormones. We will enroll a
subset of 150 COCP users into a matched case-control study to determine how CYP3A7*1C carrier status
affects ovulation inhibition using pharmacodynamic measurements of hypothalamic-pituitary-ovarian axis
suppression and dominant ovarian follicle creation. All participants will also complete questionnaires to assess
their side effect profiles after a single cycle of COCP use and undergo serial measurements of clinically
relevant biomarkers. Participants will then be given the opportunity to complete repeat questionnaires and
biomarker measurements after 3, 6, and 13 cycles of continued COCP use. This prospective collection of side
effect and biomarker data will allow for analyses of clinically pertinent phenotypes, such as early COCP
discontinuation and enhanced estrogenecity. We will utilize genome-wide sequencing for all participants so
that we can conduct exploratory genome-wide analyses in addition to our planned targeted approaches. This
study will create the first biobank of COCP users specifically designed with collecting phenotypic data most
pertinent for the eventual creation of precision and personalized medicine clinical tools. These clinical tools will
one day allow women considering steroid hormone medications to assess their individual risk for medication
failure and adverse side effects, thus leading to better informed care and increased patient satisfaction.

Public health relevance
PROJECT NARRATIVE This project aims to help us better understand how individual differences in our genes can affect some of the most commonly prescribed hormone-containing medications, combined oral contraceptive pills. Individual genetic differences may place some women at higher risk of contraceptive failure while using combined oral contraceptive pills, while other genetic differences could increase the risk of bothersome side effects that lead to early contraceptive discontinuation and higher risk of unintended pregnancies. The results of this project will help us incorporate precision and personalized medicine into individualized counseling for hormonal contraception based on individual genetic differences, leading to patients making more informed decisions about their use of hormone-containing medications.